X-RAY AND NEUTRON SCHOOL EXPERIMENTS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. As part of its dissemination strategy, BioCAT takes part in any facility wide workshops that are organized by the APS and other institutions that covers techniques supported by BioCAT. The main purpose of the National School on Neutron and X-ray Scattering is to educate graduate students on the utilization of major neutron and x-ray facilities. Lectures, presented by researchers from academia, industry, and national laboratories, will include basic tutorials on the principles of scattering theory and the characteristics of the sources, as well as seminars on the application of scattering methods to a variety of scientific subjects. As part of this activity Prof. Irving gave a lecture on non-crystalline diffraction in the formal sessions. As part of the school students conducted six short experiments at Argonne's Advanced Photon Source and Oak Ridge's Spallation Neutron Source and High Flux Isotope Reactor facilities to provide hands-on experience for using neutron and synchrotron sources. As part of this activity BioCAT hosted 14 graduate students to provide training in small angle x-ray scattering techniques. The admission process to the school is highly selective and so we view this as a highly effective way of reaching the next generation of researchers.